Joint inferences of natural selection between sites and populations

Project Summary/Abstract
There is a critical need for population genetic inference approaches to quantify natural selec-
tion within and between populations. The PI's long-term goal is to develop comprehensive
approaches for identifying selection in natural populations and understanding its functional
consequences. The objectives of this application are to develop and apply novel approaches
for inferring correlated selection between genomic sites and between natural populations.
The rationale for the proposed research is that the approaches developed will be broadly
applicable, providing a foundation understanding adaptation in pathogens and the genetic
architecture of human disease.
In Aim 1, the PI proposes to leverage his recently developed approach for calculating the
statistics of pairs of linked genetic loci to quantify several aspects of natural selection in hu-
mans and Drosophila melanogaster. He will ﬁrst focus on individual known adaptive loci,
quantifying the strength, timing, and mode of selection. He will then infer the distribution of
ﬁtness effects of new nonsynonymous mutations. Lastly, we will infer the joint distribution of
ﬁtness effects of nonsynonymous mutations within the same protein.
In Aim 2, the PI proposes to quantify divergent natural selection between populations of hu-
mans, D. melanogaster, and Daphnia pulex. To do so, he will develop an approach for inferring
joint distributions of mutation ﬁtness effects and apply it to genes sets of differing molecular
function and populations of differing divergence.
The proposed research is innovative both methodologically and conceptually. The methods
to be developed are novel, as are the concepts of joint distributions of ﬁtness effects be-
tween sites and populations. The expected outcomes of the proposed research are new
population genetic inference methods and inferences of natural selection in humans and two
model organisms. These outcomes are expected to have important positive impact on the
ﬁeld of population genetics. The methods will be widely applicable and well-supported, and
the inferences will feed into approaches for inferring the evolutionary past and predicting the
evolutionary future.
Project Summary/Abstract

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding natural selection plays a key role in combating genetic and infectious diseases. The proposed research will generate new methods for identifying both negative and positive natural selection in natural populations, including humans. These methods will form a foundation for predicting, for ex- ample, rates of adaptation of pathogens and the architecture of human genetic disease. Project Narrative